Medical Student Summer Research Training Program

The Medical Summer Student Research Program (MSSRP) at the Medical College of Wisconsin (MCW)
leverages the research and training expertise of MCW’s faculty and its substantial research infrastructure to
provide robust research training opportunities for first year medical students (M1). The goal of the MSSRP
is to expose M1 medical students to research and careers in biomedical science and academic medicine in
cardiovascular, pulmonary and blood-related fields at a critical time in their career decision-making process.
The goal is accomplished by three objectives, which are (1) to provide trainees with rigorous, hands-on,
fundamental research experiences within the basic science, clinical and/or translational research
laboratories of funded MCW investigators focused on diseases of heart, lung and blood; (2) To facilitate
opportunities for trainees to observe how new discoveries translate into the development of new drugs,
devices and treatment modalities in the clinical arena; and (3) To encourage trainees to remain connected
to research and mentoring beyond the short-term through opportunities to publish, present and participate
as Honors in Research candidates or in advanced research electives and pathways throughout their
education curriculum. The MSSRP students are engaged full-time short-term training regimen of 11 weeks
in their M1 summer year in basic science, clinical or translational laboratory studies that address diseases
and conditions affecting the cardiovascular, pulmonary or hematological health of our citizens and globally.
They have an option for additional 4 weeks of training in their M2-M4 years, which could culminate in a
manuscript or thesis submission, and thus result in “Honors in Research,” designation on their diplomas.
The training is complemented by a series of didactic seminars and other activities that deepen the
integration of the trainees into the scientific community. These experiences facilitate opportunities for
trainees to observe how new discoveries translate into the development of new drug targets, devices and
treatment modalities in the clinical arena, while also encouraging them and providing them with outlets to
remain connected to research throughout their medical education program. There is a high demand for
training and a qualified applicant pool, with good outcomes evident over the 6-10 years time span that
separates the summer training period from the beginning of an independent career. We request
continuation of 24 slots in this T35 renewal application. New leadership and advisory committee teams are
in place, and all aspects of the MSSRP has been updated to meet its current objectives. Our programs
model of exposing medical students early in their training to research opportunities is a unique and novel
approach to training the next generation of physician scientists in the workforce.

Public health relevance
The Medical Student Summer Research Program (MSSRP) aims to foster the development of biomedical, behavioral and clinical researchers among medical students who are in the early stages of their career decision-making. The MSSRP’s immersive approach exposes students to both the scientific principles underlying cardiovascular, pulmonary and hematological diseases and their translation to new clinical paradigms during intense, summer experiences encompassing laboratory and didactic training within an integrated and collaborative scientific environment. The overall goal is to help ensure that an adequate supply of diverse, well-trained physician scientists is available to address the needs of the public in these interest areas.